PSID, CDS, and TA: Data Enhancements and User Training, Support, and Outreach

Project Summary/Abstract
This project will undertake an integrated set of data enhancements and user education, support, and outreach
efforts to expand the research and policy communities’ use of data from the Panel Study of Income Dynamics
(PSID), the PSID Child Development Supplement (CDS), and the PSID Transition into Adulthood Supplement
(TAS). PSID is a longitudinal survey of a nationally representative sample of US families that began in 1968. It
has collected data on the same families and their descendants for 42 waves over 54 years (as of 2022). PSID
provides long-term measurement, over the life course and across generations, of economic, social, demo-
graphic, and health processes, which has inspired researchers to investigate the dynamics of these processes
and their interrelationships. CDS was launched 25 years ago, in 1997, to collect data on children in PSID fami-
lies. Seven waves of CDS have been completed, with three waves (in 1997, 2002, and 2007) on the original
CDS cohort of children and with two major waves (in 2014 and 2019) and two follow-up Covid-focused waves
(in 2020 and 2021) on all PSID children aged 0–17 years. Nine biennial waves of TAS have been completed.
From 2005 through 2015, TAS collected data on members of the original CDS cohort; since 2017, TAS has
collected data on all young adults aged 18–28 years in PSID families. PSID data are an unparalleled resource
for research on topics of major scientific and policy interest, such as the intergenerational transmission of
health, development, and well-being, determinants and consequences of children’s development, cohort and
period effects on children’s outcomes, children’s time use, the transition to adulthood, and many other topics.
However, the complexity and richness of these data can be challenging for new users and even for many ex-
perienced analysts. The goal of this project is to make the use of these data easier and more efficient for all
users. The specific aims of this project are to: teach an annual course on PSID data analysis geared to new
users of the data; assist researchers who encounter complex problems by providing high quality, rapid re-
sponse user-support services and through online facilities for users; undertake a variety of enhancements to
PSID data and dissemination that will make it quicker and easier for both new and experienced researchers to
conduct research with these data; conduct an annual user workshop to foster exchange and interaction among
new and experienced researchers; and increase the size and disciplinary breath of the PSID, CDS, and TAS
user community by conducting a variety of outreach efforts. The activities in this project will further increase the
widespread use of the PSID, CDS, and TAS data, and will promote efficient and productive use of these data
by new and experienced users of the data archive.

Public health relevance
Project Narrative This project will develop an integrated set of data enhancements and user education tools and activities to ex- pand researchers’ use of data from the Panel Study of Income Dynamics (PSID), the PSID Child Development Supplement (CDS), and the PSID Transition into Adulthood Supplement (TAS).